Role of Mitochondrial Quality Control in Bone Homeostasis and Disease

PROJECT SUMMARY/ABSTRACT
Altered mitochondria quality control in osteoblasts and osteoclasts has been implicated in the loss of bone mass
associated with aging and estrogen deficiency – the two most important causes of osteoporosis in humans,
however the underlying mechanisms remain unclear. Sirtuin-3 (Sirt3) is the primary mitochondrial protein
deacetylase and plays a critical role in mitochondrial quality control, including mitochondrial biogenesis,
mitochondrial dynamics, and mitophagy—all of which are affected in age-related metabolic diseases. Earlier
work aiming to elucidate the role of Sirt3 in bone has produced conflicting results with some studies suggesting
that Sirt3 is critical for skeletal homeostasis while others found no physiological role of Sirt3 in bone. We have
shown that deletion of Sirt3 or pharmacologic inhibition of Sirt3 in mice prevents the loss of bone mass caused
by aging and estrogen deficiency and this is associated with decreased bone resorption. Osteoclasts lacking
Sirt3 exhibit impaired mitophagy and increased acetylation of the mitophagy protein PTEN-induced kinase 1
(PINK1). Moreover, the mitophagy inhibitor mdivi-1 mimics the effects of Sirt3 deletion or Sirt3 inhibition on
osteoclast generation and bone resorption. We have also obtained proteomic evidence to suggest that the
protective effects of Sirt3 deletion on bone mass are mediated by its posttranslational regulation of ATPase
inhibitory factor 1 (ATPIF1), an essential protein for mitophagy. Notably, ATPIF1 silencing osteoclast progenitors
exhibit impaired polykaryon formation and resorptive activity as well as decreased mitophagy. We hypothesize
that Sirt3-mediated deacetylation of ATPIF1 promotes osteoclast function via PINK1-dependent or
independent mitophagy and that this process contributes to the excessive bone resorption that occurs
with aging and estrogen deficiency. In Aim 1 we will determine the contribution of Sirt3/PINK1-mediated
mitophagy to the development of osteoporosis in aged or ovariectomized mice with PINK1 loss-of-function. We
will also quantify mitophagy and mitochondrial architecture in vivo using a mitochondria reporter mouse. In Aim
2 we will determine the role of ATPIF1 in the actions of Sirt3 on osteoclast function. Successful completion of
this work should establish novel molecular and cellular mechanisms that contribute to osteoclast function and
osteoporosis. These studies also should elucidate a previously unappreciated deleterious role of Sirt3 in age-
related metabolic diseases.

Public health relevance
PROJECT NARRATIVE Estrogen deficiency and old age are the two most important factors for bone loss and the development of osteoporosis in both women and men, but the mechanisms responsible for this effect remain unclear. The aim of the work proposed in this application is to uncover the underlying mechanisms and this will be accomplished by studying a mitochondrial deacetylase Sirt3 and its downstream effectors in osteoclasts. Knowledge gained with these studies may prove useful for the development of therapies that can treat osteoporosis.